Personalized Cystic Fibrosis Therapy and Research Center

A key component of this P30 application is the ‘Personalized Cystic Fibrosis Model System Core’. The models will include the patient-specific cultures derived from intestinal epithelia (enteroids) and the induced pluripotent stem cells (iPSCs) from myofibroblasts. These patient-specific cultures will be used to study CFTR function and fluid homeostasis, and the information obtained will be used towards personalized treatment options. The Personalized Cystic Fibrosis Model System core will develop and bank these models, develop and validate the assays for CF/CFTR research, and distribute the resources to researchers worldwide. The long-term goal of this core is to use models derived from the patient to facilitate his/her personalized therapy. Specific Aim 1. To provide well-characterized CF patient-specific somatic epithelial cultures and iPSC to local, national, and international investigators interested in personalized model systems for CF/CFTR-related research. Specific Aim 2. Establish and provide tissues from CF patient-specific iPSC-derived intestinal and
pancreatic tissue. Specific Aim 3. To provide assay services and training to local, national, and international investigators interested in personalized model systems to study the functional involvement of CFTR fluid secretion in intestinal enteroids and spheroids. The Core will create resources and sound services that have important long-term clinical implications toward patient-specific therapies for cystic fibrosis. The core will provide training in a variety of state-of-the-art and
innovative techniques, including the development of intestinal stem cell cultures, iPSCs technology, high content microscopy, to name a few, to researchers who will be able to use these techniques to study not only CF/CFTR biology but also other membrane proteins and their associated diseases.

Public health relevance
Defects in the Cystic Fibrosis Transmembrane Conductance Regulator chloride channel are strongly associated with genetic variations in the CFTR gene that are unique to individual CF patients or subgroups within the CF patient population. Our Cystic Fibrosis (CF) Centers at Cincinnati Children’s, University of Cincinnati, and Cedars-Sinai Medical Center already have a robust research infrastructure, which was expanded through the previous P30 funding, and an excellent IRB-approved genotype-phenotype database available for clinical and research use. We intend to leverage these capabilities to develop a Personalized Cystic Fibrosis Therapy and Research Center for individual patients to determine individual susceptibility to a particular form of CF mutation and take steps to mitigate the early onset of the disease. Given the large number of people with CF in Cincinnati and Southern California, and the fact that CF patients with rare mutations have higher mortality rate compared to the more common F508del-CF patients, in this renewal application, a simple but critical question of a CF-health will be addressed ‘What are the biologic contributors that lead to better outcome in rare CF-mutations, inclusive of all people’.